Biostatistics and Bioinformatics

PROJECT SUMMARY
The purpose of the Biostatistics and Bioinformatics Shared Resource Core 2 is to provide consultation and
collaboration on quantitative methods on all SPORE Projects, Developmental Projects, and Admin Core and
Shared Resource Core 1. Successful collaboration between the project leaders and the biostatisticians and
computational biologists in this SPORE, as well as members of the other Cores, is essential to achieve the
goals of the projects. Members of this core will provide support for the design, analysis, and reporting of
laboratory, animal, translational, genomic, and clinical studies. Depending on the project, these collaborations
could range from short consultations to large collaborative projects, and will include assistance in preparation of
grant applications and manuscripts related to the SPORE projects. The Core members will also provide
statistical and bioinformatics mentoring to the researchers, with a particular emphasis on Career Development
Awardees and Developmental Project Investigators. Important for the success of the SPORE is the coordination
of data management and quality control procedures. The biostatisticians and computational biologists are an
integral part of this process at the DFCI, and will continue to provide input on the existing procedures, as well as
recommendations on additional computational infrastructure, which might be necessary for this SPORE. To
achieve the goals of the SPORE, we propose the following specific aims:
Specific Aim 1. To provide computational biology and bioinformatics collaboration for SPORE Projects,
Developmental Projects, and Cores. This includes design, preprocessing, storage, and analysis of all high
throughput genomic studies.
Specific Aim 2. To provide biostatistical collaboration for SPORE Projects, Developmental Projects, and
Cores. This includes design, conduct, analysis and reporting of laboratory and clinical protocols; including the
coordination of laboratory results with patient characteristics and outcomes from the clinical studies.
Specific Aim 3. To provide consulting and statistical education to SPORE researchers. To foster rigor and
reproducibility of all computational activities in the SPORE, the core will also provide or recommend supporting
computational infrastructure for data collection, form development, data processing, and quality assurance of
clinical trials data, as well as moving data between databases for laboratory, animal, and relevant clinical studies.

Public health relevance
PROJECT NARATIVE This core will provide biostatistical and bioinformatics collaboration to all the SPORE projects, including the design, analysis, and reporting of laboratory, animal, translational, computational biology, and clinical studies. Through these activities, the core will foster optimal use of the data generated by the projects, enable discoveries, and foster reproducibility.